Mountain States Advancement in Research, Supportive Networking and Career Development (ASCEND)

ADMINISTRATIVE CORE – PROJECT SUMMARY
The mission of our Mountain States ASCEND Advancement in Research, Supportive Networking and Career
Development Program is to train and cultivate future academic leaders in Kidney, Urology, and Hematology
(KUH) by engaging trainees via networking and programs that provide early exposure to dedicated researchers
in the ASCEND network. With fewer applicants pursuing academic careers in KUH research, there is a major
need to re-invigorate KUH specialties and excite the new generations about the joys of scientific investigation.
To accomplish this objective, we combined research and training strengths at the University of Colorado (CU)
and the University of Utah (UU). Through this collaboration, we have developed an innovative, comprehensive
training program stressing translational science, alliances between MDs and PhDs, and incorporation of the
newest scientific platforms and didactic training. The Administrative Core will be responsible for the overall
leadership, coordination, and oversight of the entire ASCEND Program (i.e., Cores and Committees) and it will
provide the required infrastructure to unite KUH researchers at CU and UU. The Administrative Core will
coordinate workflow, distribution, and access to educational and research resources and assess the
performance of the program. The Administrative Core will be led by investigators from CU and UU to enhance
and strengthen communication among Cores. Aylin Rodan, MD (UU Nephrology) will direct the Administrative
Core. Dr. Rodan is an Associate Professor, Chief of the Nephrology Division at UU, and a member of the
NIDDK Council. Judith Blaine MD PhD (CU Nephrology) will serve as Co-Director. Dr. Blaine is a Professor,
Associate Division Head for Clinical Affairs, and Clinical Director of the Nephrology Division at CU. Thus, both
directors have experience leading divisions, research programs, and training. They will be assisted by a
Program Coordinator and Manager who will assist with core functions, day-to-day operations, and
communications. To promote shared governance the Administrative Core will implement a Leadership Council
composed of Core leaders and key stakeholders from the Professional Development, Networking, and TL1
Training Cores to oversee the program. The Aims of the Administrative Core are to: 1) Provide an
organizational structure to provide direction and oversight, promote and monitor growth for all components,
and foster training and research collaboration of the ASCEND Program; 2) Ensure access for all participants to
core services and programs that advance ASCENDs collaborative research, education, and training missions;
3) Develop comprehensive program evaluation and data review to maintain the highest quality and applicability
of the program and to monitor progress and adherence to program goals; 4) Organize and host one meeting of
all NIDDK U2C/TL1 Award programs. Achieving these aims will build synergy among Cores, ensuring
collaboration and integration to create an ideal training environment for future KUH investigators.